Uncovering the proviral role of B cell-intrinsic STAT1 expression during chronic gammaherpesvirus infection

Project Summary
Human gammaherpesviruses, such as Epstein Barr virus (EBV) and Kaposi’s sarcoma-associated
herpesvirus (KSHV), are highly prevalent and are associated with several cancers, including B cell lymphomas.
Although the risk factors underlying oncogenesis are not well understood, increased viral latency and viral
reactivation likely precede the development of cancer. EBV and KSHV have a high degree of species-
specificity which limits the ability to investigate these viruses, particularly during chronic infection in vivo. To
overcome these limitations, we and others use murine gammaherpesvirus 68 (MHV68), a naturally occurring
rodent gammaherpesvirus. MHV68 is genetically related to its human counterparts and shares pathogenic
features, such as lymphomagenesis, B cell tropism, and the ability to hijack host germinal center responses for
the establishment of chronic infection. MHV68 represents a powerful model to define host parameters that
control chronic infection and viral lymphomagenesis in an intact host. Using the MHV68 model, we have
discovered a proviral role of the B cell-intrinsic expression of STAT1, the effector protein of type I and type II
interferon signaling, during chronic MHV68 infection. Specifically, B cell-specific STAT1 expression promoted
the establishment of the latent splenic reservoir and virus-driven germinal center response that seeds
lymphomagenesis. This project aims to determine the mechanism by which MHV68 usurps B cell-intrinsic
STAT1 expression to establish chronic infection. Successful completion of the proposed studies will define the
proviral mechanisms of B cell-intrinsic STAT1 expression during chronic MHV68 infection and provide insights
into potential therapeutics to target chronic gammaherpesvirus infection and the development of associated
cancers.

Public health relevance
Project Narrative Gammaherpesvirus infection is lifelong and is associated with the development of cancers, such as B cell lymphoma. This project explores the novel, proviral role of B cell-intrinsic STAT1 expression, an effector protein of type I and type II interferon signaling, during chronic gammaherpesvirus infection. Understanding the role of B cell-intrinsic STAT1 expression is critical to understand how chronic infection is established in a host and may provide insights about therapeutic targets for virus-driven cancers.